The Impact of Leukocyte-derived Cytokines on Ovulation in Humans

PROJECT SUMMARY/ABSTRACT
Mid-cycle gonadotropin-induced ovulation, a pivotal event in female reproductive physiology, shares
many features with an acute inflammatory response, notably marked by a substantial influx of leukocytes into
the dominant follicle. Despite this, the precise impact of leukocytes on the ovulatory process remains largely
uncharted territory. This knowledge gap serves as the foundation of the proposed study, which endeavors to
elucidate the role of leukocytes in facilitating ovulation and luteinization in the human ovary. Our preliminary
findings, derived from single-cell RNA sequencing (scRNA-seq) analysis using follicular aspirates obtained
from in vitro fertilization patients (due to male factor or egg donation), have revealed the presence of ten
distinct leukocyte subpopulations. Furthermore, based on the single-cell transcriptomic datasets, we found that
inflammatory cytokines are exclusively expressed in leukocytes, while the expression of their corresponding
receptors is abundantly detected in follicular (granulosa and theca) cells. Therefore, we hypothesize that these
cytokines and their receptors play a pivotal role in ovulatory changes, including steroid hormone and
prostaglandin production, as well as cell metabolic shifts in the human periovulatory follicle. In Specific Aim 1,
we will comprehensively delve into characterizing the expression profile of these cytokines and their
corresponding receptors in dominant follicles throughout the ovulatory period, analyzing samples obtained from
regularly cycling women before and at defined hours after human chorionic gonadotropin (hCG) administration
to understand spatiotemporal dynamics of leukocyte-derived cytokines and their corresponding receptors. Also,
we will determine the regulatory mechanisms by which hCG increases the expression of the receptors for the
leukocyte-derived cytokines using primary human granulosa/lutein cells (hGLCs). Specific Aim 2 focuses on
elucidating the impact of these leukocyte-derived cytokines and their corresponding receptors in granulosa
cells on the ovulatory process. By treating hGLCs with hCG, cytokines, and/or receptor antagonists, we aim to
uncover the underlying signaling pathways and associated functional changes facilitating ovulation and luteal
formation in the human ovary. The implications of this proposed study extend beyond advancing our
understanding of normal ovulation; it also holds significant promise for addressing female infertility caused by
inflammation-related ovarian conditions. By shedding light on these intricate mechanisms, our research has the
potential to provide invaluable insights into the development of innovative therapeutic strategies aimed at
improving women’s reproductive health and fertility.

Public health relevance
PROJECT NARRATIVE The gonadotropin surge-induced ovulatory changes include the infiltration of leukocytes into the dominant follicle, implying a significant role of leukocytes in the ovulatory process; however, underlying mechanisms remain elusive. Our pilot single-cell transcriptomic data using human follicular aspirates revealed specific cytokines produced by leukocytes and their corresponding receptors in follicular cells, indicating a collaborative role of leukocytes and follicular cells in successful ovulation. Consequently, the proposed study will characterize leukocyte-derived cytokines and their receptors in the human dominant follicle and elucidate their actions and roles in periovulatory granulosa cells, thereby better understanding the mechanisms of how leukocytes facilitate the ovulatory process and luteal formation in the human ovary and its impact on female fertility.